Medical Scientist Training Program

ABSTRACT This application is being submitted to PA-20-272 in accordance with NOT-GM-21-023. The Baylor College of Medicine (BCM) Medical Scientist Training Program (MSTP), supported by NIGMS T32 GM136611-01, has, over 49 years of continuous funding from the NIH, established a successful track record of training physician scientist leaders. Research mentor training is an evidence based and critical component of the training program that enhances trainee retention and productivity, promotes diversity and inclusion, and supports the career development of research faculty. This proposal expands the pool of facilitators available to conduct mentor research training at BCM by supporting facilitator training of one MSTP Co- Director and two MSTP Faculty Operating Committee faculty members. These three new certified workshop facilitators will teach the National Research Mentor Network “Entering Mentoring” curriculum to primary research mentors of MSTP students, enabling compliance with the program’s new requirement for universal research mentor training. The impact of research mentor training will be assessed by evaluating program-specific outcomes such as publication rate, time to degree, and student retention, including comparison of these metrics for students from underrepresented groups and women. Faculty responses to training and student perspectives on mentor-mentee interactions will also be longitudinally assessed. This enhanced research mentor training program is envisioned to be sustainable, as trained facilitators will continue to provide regular training sessions on a semiannual to quarterly basis including at the annual MSTP retreat. The program is designed to reach across all 7 programs at the BCM Graduate School for Biomedical Sciences, and to translate into improvements in all other T32 training programs at BCM.

Public health relevance
PROJECT NARRATIVE Research mentor training is an evidence-based strategy to improve research outcomes and enhance diversity and inclusion in the biomedical workforce. This award is designed to expand the pool of research mentor training facilitators for the Baylor College of Medicine Medical Scientist Training Program, which has instated a new research mentor training requirement for the primary research mentors of students in the program. The impact of universal training will be assessed through evaluations of the training program, research mentors, and mentees, so as to improve T32-funded research training throughout the College.